Development of plasmon-enhanced biosensing for multiplexed profiling of extracellular vesicles

The parent R01 project aims to advance nanoplasmonic sensing technology for robust multiplexed
extracellular vesicle (EV) analysis and good reproducibility. The developed technology is validated using well-
established preclinical and clinical samples to demonstrate the feasibility and potential of the new technology
for clinical applications. In the course of the project, we have generated a large amount of imaging data from
cells and EVs that are originating tumor and non-tumor models, as well as human clinical samples. This
provides a new opportunity to develop a deep learning model to analyze high-dimensional and high-variate
imaging data for machine-derived classification and uncover new insights. For robust deep-learning models,
however, the quality of training data, besides the quantity of the data, is critical. Unbalanced data or embedded
technical confounding factors often lead to the deep- or machine-learning models' decisions based on non-
related or arbitrary parameters. Another problem is making false classifications when new input data is different
from the data used for training, which is called out-of-distribution samples. These issues significantly hampered
the deep-learning models' robustness with variable results and accuracies, resulting in disappointment and
reduced enthusiasm for using AI models. The goal of this Administrative Supplement to the Parent R01 project
is to develop a deep-learning-based data management software that digests massive cellular and molecular
imaging data and produces balanced, confounder-free data sets ready for new deep- or machine-learning
tasks. Specifically, we will design the algorithm for general users who do not necessarily have knowledge of
the deep-learning framework. We will apply and test the software for multi-channel EV imaging data generated
from the Parent R01 project and other cellular and EV imaging data from the past NIH project and other
laboratories. The final software package and AI-ready data will be publicly shared with other researchers, and
we will continuously provide feedback and updates through our IT core team. We envision that the software will
offer a unique opportunity for researchers to create quality training data ready, reduce the technical barrier for
researchers, and promote the use of their data for deep- or machine-learning models.

Public health relevance
The parent project aims to develop a new nanoplasmonic system capable of robust, multiplexed analysis of extracellular vesicles. The administrative supplement project is to develop deep-learning models to process the collected data and produce a balanced, confounder-free set for deep- or machine-learning models.